Platelet mass microarchitecture as a regulator of thrombin production

Project summary
Thrombin is a critical element of the hemostatic/thrombotic response, as evidenced by the large number of
clinically relevant pro- and anti-coagulant therapies designed to regulate its generation or activity. Thrombin
regulation is not a purely biochemical matter, but rather it emerges from the interaction of the biochemical
cascade with the evolving physical microenvironment (i.e., platelet deposition). As such, in order to determine
how reaction rates of the coagulation cascade may be impacted inside of a hemostatic (or thrombotic) mass we
need to study the tightly-woven interaction between the biochemical reactions responsible for thrombin
generation and the physical environment in which they occur. Our primary objective is to answer a fundamental
question: can the narrow pores of a hemostatic mass operate as a ‘molecular barrier’ and terminate thrombin
generation? If so, this would represent an understudied mechanism mediated by platelets and/or fibrin, and the
structure they form following accumulation, at a site of injury. The hypothesized molecular barrier results from
the hindered movement of soluble species through the evolving hemostatic mass microenvironment. Hemostatic
masses are defined by a complex network of mesoscopic scale pores with dimensions of a few to tens of
nanometers, and as a result, biochemical reactions relevant to clotting occur in extremely confined spaces.
Previous studies explored the idea that the physical environment of a hemostatic plug may contribute to
regulating the hemostatic response, but an accurate knowledge of the microstructure of a hemostatic mass
remains elusive. Our proposed studies will address this bottleneck by combining novel volume imaging electron
microscopy methods of hemostatic masses with artificial intelligence methods to create anatomically realistic
domains for simulations of coagulation biochemistry. In Aim #1, in collaboration with Dr. Weisel (letter attached),
we will acquire sequential image stacks of hemostatic masses formed in vivo using correlative multi-photon
fluorescence and Focused Ion Beam Scanning Electron microscopy. In Aim #2, we employ artificial intelligence
methods to perform accurate image-driven 3D reconstruction of hemostatic mass microarchitectures, using the
image stacks generated in Aim #1. As part of a related research project, we have already acquired an initial set
of transmission electron microscopy images of hemostatic thrombi at single-platelet resolution to guide our initial
computational efforts. In Aim #3, we will use the reconstructions obtained to examine how the hemostatic mass
microarchitecture impedes molecular transport. We will evolve simulations to systematically evaluate how pore
size and molecule size interact to regulate molecular diffusion. Finally, we will ask whether limitations in
molecular transport through the hemostatic mass are responsible for the termination of thrombin production at a
local level. If confirmed, this mechanism will represent a fundamental shift in the way we understand the role of
platelet activation and accumulation, the hallmarks of hemostasis and thrombosis.

Public health relevance
Project Narrative The coagulation biochemical cascade and platelets work together as part of the normal response to vascular injury, called hemostasis, producing a plug that limits blood loss. By contrast, an improper hemostatic response results in numerous clinical problems, including excessive bleeding (e.g., hemophilia), or vascular occlusion that damages tissues such as the heart and brain (i.e., heart attacks and strokes). The goal of this project is to understand if the biochemical reactions of the coagulation cascade are regulated by the architecture of the hemostatic plug, and then translate that understanding into improved methods to treat disorders of the hemostatic system.